An upgraded experimental hutch vacuum system for improved safety and operations for the BioCAT Facility at the Advanced Photon Source

The purpose of this administrative supplement request is to acquire hardware that will allow us to assemble
“An upgraded experimental hutch vacuum system for improved safety and operations for the BioCAT Facility at
the Advanced Photon Source. This new vacuum system will allow us to significantly reduce instrumental
backgrounds for all experiments but also to protect both personnel and very expensive equipment from
damage due to catastrophic failure of the evacuated flight paths in the SAXS instrument.

Public health relevance
The BioCAT resource will continue to provide state-of-the-art facilities with unique capabilities for muscle/fiber diffraction and macromolecular SAXS to the bio-medical and structural biology community. The purpose of this proposed administrative supplement is to acquire a new vacuum system will allow us to significantly data quality for all experiments but also provide protection for both personnel and very expensive equipment from damage.